Designing and evaluating a Single-session Transdiagnostic intervention for Emotion Regulation with follow-up mHealth support for domestic violence survivors

Domestic violence (DV) is a widespread public health concern. A staggering 35.6% of American women report rape, physical violence and/or stalking by an intimate partner in their lifetime. Although DV causes posttraumatic stress disorder (PTSD) and depression, the unmet needs for mental health care for women are massive. Drivers of this care gap include 1) a lack of treatments relevant for DV due to continuous traumatic stress conditions, 2) a shortage of skilled providers, 3) high drop-out following initial treatment sessions. The objective of this 5-year mixed-methods proposal is to develop and test a novel low intensity psychosocial intervention delivered to DV survivors in Mass General Brigham's (MGB) primary care clinics in Massachusetts, United States (U.S.), by nonspecialists through task-sharing—a critical strategy that successfully addresses treatment gaps for mental health. Dr. Patel (PI) will develop and test a brief intervention that is evidence-informed and brief using a single-session intervention (SSI) format, which is clinically effective for many disorders among youth yet remains less-studied among adults. The SSI will target emotion regulation to build resilience rather than actively processing trauma memories, as DV may be ongoing for many women. Dr. Patel aims to sustain the clinical effects of the SSI with ecological momentary intervention (EMI) follow-up via interactive chatbot to encourage skills practice in daily life. In Aim 1, Dr Patel will design the intervention (Aim 1a: SSI development; Aim 1b: EMI development). In Aim 2, she will conduct a case series (n=24) to optimize the content and delivery processes of the intervention. In Aim 3, Dr Patel will pilot a randomized clinical trial (N=90) with three arms (SSI alone; SSI+EMI; and enhanced usual care alone) to evaluate the acceptability and feasibility of the two interventions and assess their preliminary effectiveness. She will base her research at MGB, which has many primary care clinics in and beyond Boston, Massachusetts. The project research aims are integrated into Dr. Patel’s training aims to fill critical gaps in (1) designing scalable psychosocial interventions for trauma-exposed people, (2) mastering the design and deployment of mobile health (mHealth) support tools, such as EMI, to supplement in-person care, and (3) leading RCTs with high ecological validity in ‘real-world’ public health settings. The exceptional training environment at MGB and the world-class mentoring team with complementary expertise for all training goals foster the success of this study. This K23 award will support Dr. Patel in gaining the methods expertise and preliminary data to pursue an independent research career. Her long-term goal is to develop, evaluate, and scale a suite of psychosocial services for trauma survivors.

Public health relevance
Domestic violence (DV) is highly prevalent in the United States (U.S.) (35.6%), but the health system lacks a psychosocial response for DV-linked posttraumatic stress disorder (PTSD) and depression, leading to treatment gaps. This project addresses an urgent public health need by developing and testing a transdiagnostic single-session intervention with follow-up mHealth support (via an interactive chatbot) in Mass General Brigham's (MGB) primary care clinics in Massachusetts. As this project combines two low-intensity intervention formats to address engagement and adherence challenges, uses non-specialist providers to address a lack of expert providers, and capitalizes on the ubiquity of mobile phones to strengthen follow-up skills practice, we expect this study to greatly improve effective coverage for DV survivors with PTSD and depression and contribute to the NIMH priority area of mental health research on designing and evaluating interventions that can be integrated into routine care settings.